Investigating the role of Lipocalin Prostaglandin D2 Synthase and its metabolite PGD2 in non-alcoholic fatty liver disease

PROJECT SUMMARY/ABSTRACT
Despite non-alcoholic fatty liver disease (NAFLD) being the most common chronic liver disease worldwide,
molecular mechanisms contributing to its etiology and progression are still unclear. This gap in knowledge has
prevented the understanding of basic biology, pathogenesis, and the development of novel therapeutics for
NAFLD. There is currently no FDA-approved therapy for NAFLD. A vast majority of prior studies that investigated
NAFLD were performed primarily on obese models since obesity and NAFLD are strongly intertwined. Despite
these studies, the role of insulin resistance in NAFLD is unclear. Interestingly, our preliminary data demonstrated
that L-PGDS knockout mice exhibited a NAFLD phenotype along with significant insulin resistance and weight
gain on high-fat diet. Lipocalin Prostaglandin D2 Synthase (L-PGDS) functions as a prostaglandin synthase
where it catalyzes the isomerization of PGH2 to PGD2. PGD2 regulates its physiological function through two
individual G-protein coupled receptors named DP1 and DP2. Therefore, we hypothesized that the lack of PGD2
will induce fatty liver disease possibly involving hepatic insulin resistance and obesity. The objective of this
SuRE First application is to investigate the role of L-PGDS and its metabolite PGD2 in NAFLD. Aim 1 of the
current proposal is dedicated on elucidating the effect of insulin signaling on L-PGDS mRNA and protein
expression, localization, and function. Next, we will be investigating the role of L-PGDS on glucose and lipid
metabolism through studying energy substrate utilization, glycolysis, and fatty acid oxidation. Additionally,
metabolomics and transcriptomics unbiased approaches will discover L-PGDS-regulated signaling pathways in
NAFLD. Aim 3 is dedicated to determining the role of PGD2 receptor modulators, DP1 and D2 receptor agonist
and antagonist, in NAFLD using insulin-resistant HepG2 cells and db/db mice subjected to high fat diet. The
significance of the proposed research is that, once hepatic regulation of L-PGDS signaling is understood,
targets for NAFLD pharmacotherapy could be developed. This work is innovative as it elucidates the novel role
of L-PGDS in fatty liver disease and defines its link to insulin resistance and obesity that is supported by our
preliminary data. Collectively, our research will shed new light on the role of L-PGDS in liver physiology and
diabetes- and obesity-induced NAFLD and discover new therapeutic targets for future studies.

Public health relevance
PROJECT NARRATIVE Non-alcoholic fatty liver disease (NAFLD) has emerged as the most prevalent chronic liver disease with increasing incidence rates worldwide; but no FDA-approved treatments are available currently. Absence of Lipocalin Prostaglandin D2 Synthase (L-PGDS) developed fatty liver disease accompanied with insulin resistance and weight gain in mice; however, the precise role of L-PGDS in NAFLD is unknown. Research in this SuRE First (R16) proposal will investigate the molecular mechanisms of signaling by L-PGDS and its metabolite PGD2 that has potential for the discovery of novel NAFLD therapeutic targets.